CORTICOSPINAL MECHANISMS FOR HIGH FAT DIET IMPEDING STROKE RECOVERY

ABSTRACT The goal of this project is to provide funding support to an excellent young scientist who qualifies as a underrepresented individual per NIH criteria. This funding will provide key support to allow this individual to contribute to stroke research and form an independent career following their professional goals to become a principal investigator of their own laboratory. Stroke is a key health issue and its chronic motor impairments continue to be a major source of disability and detriment to activities of daily living and quality of life. An important knowledge gap for this health issue is the need to understand the neuronal control of volitional lower extremity movement both during healthy and stroke-injured conditions. This proposal addresses this knowledge gap by using two sophisticated brain stimulation techniques to activate and test the lower extremity cortical motor control pathway. In Aim 1, we propose to use electrical Long Train Intracortical Microstimulation (LT-ICMS) to stimulate motor cortex as it has not previously been used to study stroke recovery in laboratory mice. Further, LT-ICMS produces more complex motor outputs (relative to other forms of brain stimulation), that may be more ethologically-relevant, and the timing of its neural activation may more closely match natural brain activity during wake-behaving movement. We seek to expand on preliminary findings that suggest there are specific forms of LT-ICMS-measured cortical remodeling during poor and exceptional stroke recovery that may guide how we treat individuals after stroke. In Aim 2, we propose to use optogenetics to specifically stimulate the corticospinal circuitry responsible for movement of the lower extremities. The canonical view of the corticospinal tract is that it is a synaptic circuit, from layer 5 pyramidal cells (L5PCs) in motor cortex, to spinal motor neurons that themselves signal skeletal muscle. L5PCs that project to lumbar spinal cord (lumbar-projecting) are thought to control lower extremity function. Here we propose to introduce photo-sensitive channelrhodopsin variant 2 (ChR2) into lumbar-projecting L5PCs by back-tracing these neurons from lumbar spinal cord using adeno- associated virus of retrograde serotype (AAVrg). This AAVrg targets axonal terminals and results in genetic manipulation of the targeted cells without spreading further across additional synapses. We then plan to deliver intracortical optical blue light, using the same pulse parameters as electrical LT-ICMS, to selectively activate lumbar-projecting L5PCs in motor cortex by stimulating their artificial ChR2. Given that blue light stimuli will selectively activate neurons that express ChR2, this approach will allow direct testing of corticospinal circuitry responsible for movement of the lower extremities using highly-specific targeting of this cell population in order to guide future therapeutic treatment based on its precise deficits after stroke. Together, these aims provide a careful and rigorous determination of how voluntary lower extremity function is changed during stroke recovery and give an opportunity for an underrepresented investigator to continue their research and academic success.

Public health relevance
PROJECT NARRATIVE The inclusion, training and professional development of underrepresented individuals is an essential goal of many fundamental institutions including the NIH. Support is requested here to provide post-doctoral training to an excellent young scientist, who is eligible for this mechanism, in order to further their professional advancement and help define how reorganization of the corticospinal motor pathway supports recovery from stroke. The overall goal of this request is to support a diversity candidate at our institution and improve stroke recovery outcomes by guiding future treatments.